Role of Toll-like receptor-induced short non-coding RNAs in innate immune response

Project Summary and Abstract
Infection of microbes causes a wide range of symptoms and diseases. Sustained efforts to understand the
mechanism of cellular defense systems against microbe infections are essential to develop effective prevention
methods and therapeutic applications. The innate immune system deploys various pattern-recognition receptors,
including Toll-like receptors (TLRs), to recognize the invasion of microbes and initiate protective responses.
TLRs are expressed at the cell surface or intracellular compartments (e.g., endosome and lysosome) in various
cell types, such as macrophages, and recognize pathogen-associated molecular patterns (PAMPs) such as
lipopolysaccharide (LPS) and peptidoglycan (PGN). The PAMP recognition initiates signal transduction
pathways that culminate in the activation of transcription factors such as NF-κB, resulting in production of
cytokines and chemokines to protect the host. Following transcriptional regulation, the downstream of TLR
pathways involves regulation at multiple levels including post-transcription steps. In this context, short non-
coding RNAs (ncRNAs) including those derived from transfer RNAs (tRNAs) have evolved as key post-
transcriptional regulators. tRNA halves constitute a major subgroup of tRNA-derived ncRNAs and have been
shown to be expressed as functional RNAs associated with various biological pathways and linked to human
diseases such as neurodegenerative diseases and cancers. The goal of our proposed studies is to elucidate the
expression profile and molecular function of tRNA half molecules whose accumulation is involved in the innate
immune response. We recently found that the infection of Mycobacterium bovis BCG upregulates the expression
of tRNA halves in human monocyte-derived macrophages (HMDMs). Furthermore, the expression of tRNA
halves in HMDMs is upregulated by the activation of surface membrane TLRs, allowing us to define the tRNA
halves as a novel class of TLR pathway-dependent tRNA halves. Importantly, tRNA halves are abundantly
accumulated not only in TLR pathway-activated HMDMs but also in their extracellular vehicles (EVs) and have
functional significance in activation of endosomal TLR pathway, suggesting that those tRNA halves are
expressed as functional molecules promoting immune response. These results have led us to hypothesize that
tRNA halves can be integral elements in the innate immune response. We propose to comprehensively identify
the expression profiles of TLR pathway-induced tRNA halves in HMDMs and their EVs (Aim 1), to investigate
the biogenesis mechanism how the production of tRNA haves are induced by TLR pathways (Aim 2), and to
elucidate the molecular function of tRNA halves in endosomal TLR activation (Aim 3). Our study will reveal a
novel tRNA-engaged ncRNA pathway in the innate immune response and may support the future exploration of
biomarkers and efficacious therapeutic applications targeting tRNA half molecules upon microbe infection.

Public health relevance
Project Narrative The innate immune system deploys various pattern-recognition receptors, including Toll-like receptors (TLRs), to detect the infection of pathogenic microbes and initiate protective responses. We recently discovered a novel class of transfer RNA (tRNA)-derived non-coding RNAs (ncRNAs) which are abundantly accumulated upon activation of TLR pathways in macrophages and their extracellular vehicles (EVs). The goal of the proposed project is to characterize the expression profile, biogenesis mechanism, and molecular function of the TLR pathway-induced tRNA-derived ncRNAs in human macrophages and their EVs, which will represent novel research efforts to clarify tRNA-engaged pathway in the immune response and may support future exploration of biomarkers and efficacious therapeutic applications targeting the tRNA-derived ncRNAs in microbe infection.